Serotonin modulated mitochondrial dysfunction in Depression Diabetes and Dementia (3Ds)

Project Summary
Our research aims to understand the role of serotonin modulated mitochondrial biogenesis in diabetes,
depression, and dementia (Alzheimer's disease, AD). Diabetes and depression are independent risk factors for
dementia and worsen the dementia pathology and therapeutic response. Depression comorbidity impaired
metabolic function such as hyperglycemia, insulin resistance, inflammation, and oxidative stress results in
physical depression and cognitive impairment. Serotonin is an essential neurotransmitter that performs
synaptic transmission, plasticity, energy homeostasis in aging and dementia. For a long time, it is known that
the brainstem harbors unique neurons to synthesize and project serotonin to the entire central nervous system.
However, molecular links between serotonin levels and mitochondrial biogenesis, mitochondrial dynamics,
mitophagy/autophagy in dementia, diabetes, and depression are not entirely understood. It is established that
serotonin synthesis in dorsal raphe is protective and essential for cell homeostasis and energy metabolism. It
has been hypothesized that low serotonin levels induce defective mitochondrial biogenesis, impaired
mitochondrial dynamics, mitochondrial dysfunction and defective mitophagy/autophagy in depression,
diabetes, and dementia, and selective serotonin reuptake inhibitors, such as citalopram treatment reverses
defective mitochondrial biogenesis and all mitochondrial defective aspects. We have conceptualized the study
in rodents focusing on the transgenic models of 3Ds focusing hippocampus (APP, Tau, HT22 cells),
hypothalamus (DbDb, mHypo cells), and raphe (TPH2/ko, RN46A-B14 cells). Therefore, the current study
proposes to understand the pathologies and the protective effects of citalopram (SSRI) against defective
mitochondrial biogenesis, impaired mitochondrial dynamics, and defective mitophagy/autophagy. The outcome
of our proposed experiments will provide new insights into the role of serotonin in depression, diabetes, and
dementia concerning mitochondrial biogenesis, mitochondrial dynamics, mitochondrial function, and
mitophagy/autophagy. The outcome will also provide beneficial effects of citalopram against common
serotonin-induced defects of mitochondrial dynamics, mitochondrial function, and mitophagy/autophagy.

Public health relevance
Project Narrative The purpose of our study is to investigate mitochondrial dysfunction modulated by neurotransmitter serotonin and protective role of SSRI in depression, diabetes, and dementia (3Ds). Our study will be conducted using three transgenic mouse models and three cell models representing 3Ds pathology and representing 3 major brain areas. The outcomes of this research will provide information on whether citalopram confers protective effects comorbid effect on depression, diabetes and dementia.